HIV Vaccines

ABSTRACT Support is requested for a Keystone Symposia conference entitled HIV Vaccines, organized by Drs. Nicole A. Doria-Rose, Thumbi Ndung'u and Gunilla Karlsson Hedestam. The conference will be held in Whistler, British Columbia from March 24-28, 2019. Despite dramatic progress in prevention and treatment of HIV, the pandemic continues, and two million people are newly infected each year. Thus, the need for a preventive vaccine for HIV is as urgent as ever. Intensive research in basic immunology and virology as well as empirical clinical trial data continues to yield insights that inform vaccine efforts. The 2019 HIV Vaccines conference will present the latest results from human clinical studies of candidate vaccines as well as the use of monoclonal antibodies for prevention; novel HIV neutralizing antibodies and their developmental pathways; T cell functions in killing and B cell help; structural insights and immunogen design; and the intersection of research for HIV eradication/cure with research on HIV vaccines, including interventions after very early antiretroviral therapy. We will also include a session on the process of bringing candidate vaccines to clinical trial, told from the diverse perspectives of laboratory investigators, industrial production, funders, and clinical researchers on the front lines.

Public health relevance
PROJECT NARRATIVE Despite dramatic progress in prevention and treatment of HIV, the pandemic continues, and two million people are infected each year. Intensive research in basic immunology and virology, as well as, empirical clinical trial data continues to yield insights that inform HIV vaccine efforts. An enormous effort is pouring into the design of immunogens that can induce broadly neutralizing antibodies, and parallel efforts to understand how to induce more potent, durable antibody responses with selective adjuvants and novel methods of delivery. This conference will occur at a critical time of novel structure-based designs of immunogens to induce antiviral antibodies, as well as renewed efforts to understand how to induce effective T cell immune responses irrespective of human host genetic background.